Development of a transdiagnostic intervention for adolescents at risk for serious mental illness

Summary
Subclinical psychotic symptoms are a pluripotent transdiagnostic risk factor, associated both with an
increased risk of subsequently developing a serious mental illness (psychotic or non) and current psychiatric
distress. However, attempts to prevent the onset of these chronic illnesses in individuals with subclinical
psychotic symptoms have had limited success. This may be due to the majority of prior studies focusing on a
relatively late stage of risk, when the illness processes are possibly well underway and thus more difficult to
reverse. Intervening earlier in the lifespan, during adolescence - a time characterized by high levels of
neuroplasticity - could be particularly important for preventive interventions, while also addressing the highly
pressing current need for more mental health services for youth.
During the past few years, we have developed and tested a brief, group-based intervention for young
adults, called Resilience Training (RT). RT focuses on increasing capacities that support social functioning,
including social cognition, the neuropsychological processes involved in accurately perceiving others and their
mental states. When these capacities are enhanced, such improvements may lead to lower rates of
psychopathology. In two published trials, we have reported that RT led to reductions in a range of symptoms
and improved social functioning. Additionally, improvements in social cognition, particularly in Theory of Mind,
the ability to understand the mental states of others, are linked to RT-related decreases in psychiatric
symptoms and improvements in social functioning in this at-risk young adult group.
Based on these prior findings, the goal of the proposed project is to adapt RT for at-risk adolescents
who will be recruited using a brief mental health screening administered in their high schools, which will identify
those who have subclinical psychotic symptoms but are not yet receiving any mental health treatment. We will
first test the adapted intervention for its feasibility and acceptability in this population, and then conduct a pilot
randomized, waitlist-controlled trial, to test for its efficacy in reducing transdiagnostic symptoms and improving
social functioning. We will also measure whether the proposed target mechanism of the intervention, social
cognition, plays a role in any intervention-related improvements. If the hypotheses of this project are confirmed,
it will be followed by a definitive, longitudinal, randomized control trial, which will measure the efficacy of this
novel intervention for preventing disability in transdiagnostically at-risk adolescents.
During the course of this project, with the guidance of a highly experienced multi-disciplinary
mentorship team, coursework, and a comprehensive training plan that involves training in research on social
cognition, adolescent mental health, longitudinal biostatistics, and intervention adaptation, the applicant will
develop the necessary knowledge and skills to become an independent intervention researcher, focused on
developing approaches for the prevention and treatment of serious mental illnesses in young people.

Public health relevance
Project Narrative The proposed research will develop and test an intervention, Resilience Training for Teens, which aims to reduce transdiagnostic symptoms and improve social cognition and social functioning in adolescents who are at an elevated risk for a serious mental illness. Thus, this project could provide the basis for a novel, mechanism-based approach to improving outcomes and reducing severe disability in transdiagnostically at-risk adolescents. This project, through a set of four training goals, coursework, and a strong mentorship team, will provide this candidate with the additional training needed to become an independent intervention researcher.